2023 Translation Machinery in Health and Disease GRC/GRS

Project Abstract
Partial support is requested for the Translation Machinery in Health and Disease-Protein Synthesis and Cellular
Synergy Gordon Research Seminar and Gordon Research Conference to be held in Galveston, Texas on
February 19-24, 2023. It is the first and to our knowledge, the only, disease-focused, interdisciplinary meeting
on mRNA translation. Unlike other conferences that mainly focus on the structure of the translational machinery
and its function in protein synthesis, the focus of this GRC is on the role of translation in human disease and its
alternations on pathological consequences. This unique conference provides a forum for scientists to discuss
their findings with an ultimate long-term goal of building collaborations toward understanding and finding
treatments for disease. The specific aims of the Gordon Research Conference are to convene 50 speakers and
an additional 125-150 participants who are experts in the fields of neurological disease, stress and aging, cancer,
infectious diseases, ribosomepathies, rare diseases, mitochondrial diseases and metabolic diseases to discuss
basic science and therapeutic interventions. The accompanying Gordon Research Seminar will provide a forum
for scientists in early stages of their career to present their research on translation and disease and networking
activity. The invited speakers, other attendees, and early stage scientists will have many opportunities to talk to
researchers in other areas of translation research, exchange ideas and concepts among different disciplines,
and develop new collaborations. Dr. Susan Ackerman, an expert in translation aspect of neuroscience and
neurodegeneration, and Dr. Jonathan Weissman, an expert in translation in human biology will give keynote
lectures at the Gordon Research Conference, and Dr. Katrin Karbstein, an expert on ribosome assembly and
function will give the keynote at the Gordon Research Seminar. In addition to invited speakers and speakers
chosen from the abstracts, four poster sessions will enable all participants to contribute to the meeting. There
will be many opportunities for young investigators, women, and minorities to interact with senior leaders in the
translation field. The conference also includes a GRC-sponsored “power hour” which will provide a platform to
discuss challenges that women and other underrepresented minorities face in science. As the first and only
conference on translation and disease, this conference will significantly impact the participant's understanding
of several major disease mechanisms that are of interest to several NIH institutions. This meeting provides a
critical “translational” venue for investigators studying translation.

Public health relevance
Project Narrative The 2023 Translation Machinery in Health & Disease GRC and GRS continues to be the only disease focused, interdisciplinary conference for the broad field of translation. Translation is central in converting genetic information into proteins in all organisms. Alternations in this process and its machinery cause cancer, neurodegeneration, infectious, ribosomepathies, and other diseases. This GRC and GRS will gather experts in the field to discuss how to better understand these processes and their relationship.